Headache Assessment of Children for Emergent Intracranial Abnormalities

Project Summary
Annually, over 400,00 children present to emergency departments (EDs) across the U.S. with headaches as
their chief complaints. Although a small proportion (0.5-1%) of these children will have brain abnormalities
requiring emergent identification, such as tumors, bleeding, or strokes, a much larger proportion undergo
neuroimaging of the brain in the ED. Approximately, one-third of children with headaches are receiving
unnecessary imaging that increases their exposure to risk associated with neuroimaging. The goal of the
Headache Assessment of Children for Emergency Intracranial Abnormalities (HEADACHE) study is to
generate definitive evidence that will aid clinicians in determining risk of emergent intracranial abnormality to
help identify need for neuroimaging. The primary aim of HEADACHE is to derive and internally validate a
decision tool that stratifies the risk for children presenting to EDs with headaches. HEADACHE is a prospective
multicenter study planning to enroll 28,000 children 2-17 years old with headaches presenting to one of 18 EDs
in the Pediatric Emergency Care Applied Research Network (PECARN). Follow-up for children with headache
is essential for providing optimal symptom management and ensuring that necessary diagnostics or
consultations are obtained, particularly if neuroimaging is not obtained in the ED. Few data exist, however, to
determine whether disparities exist in accessing timely follow-up for children with headaches evaluated in EDs.
Timely follow up can include primary care provider (PCP) follow-up, neurology follow-up or outpatient
neuroimaging if indicated. This diversity supplement will enhance the HEADACHE study by gaining an in-depth
understanding of the barriers and challenges experienced by caregivers of children with headaches when
seeking follow-up care for their children after the initial ED visit. The specific aims of this diversity supplement
are: (1) to determine whether insurance status and/or race/ethnicity are independently associated with the time
to and rate of recommended follow-up to see a PCP or a neurologist, (2) to determine whether insurance
status and/or race/ethnicity are independently associated with obtaining neuroimaging and the type of
neuroimaging obtained after ED discharge, and (3) to quantitatively and qualitatively explore the caregivers'
lived experiences to identify barriers to timely PCP or neurology follow-up among underinsured/publicly insured
and/or racial/ethnic minoritized children presenting to the ED with headaches.

Public health relevance
Project Narrative Children commonly present to the emergency department with headache and follow-up is essential for ongoing symptom management and further diagnostics or consultations, particularly if neuroimaging is not obtained in the ED. This diversity supplement will help to determine whether disparities exist in accessing timely follow up for children with headache who were evaluated in the ED. This diversity supplement provides the unique opportunity to fill gaps in knowledge about barriers to follow-up care for children seen in the ED with headaches and gain rich data about lived experiences so that we can then develop and implement interventions that improve equitable access to follow-up care for children with headaches.